Hand Rehabilitation using Variable Assistance through Force and EMG Feedback

DESCRIPTION (provided by applicant): This project proposes to develop and evaluate a hand rehabilitation system for chronic hemiparetic stroke survivors that have lost their ability to full control their hand. Stroke is the leading cause of adult disability, and is the third leading cause of death in the United States. Stroke survivors often face a significant loss of functional motor control in the upper limbs of the contralesional side of the body. Restoration of upper limb function is particularly difficult due to its enormous complexity. User control of hand movement is crucial to regaining correct central motor control. It has been shown that the paralyzed hand can be improved through repetitive training of isolated movements. This program will direct development efforts towards a hand rehabilitation system that provides adaptive assistance as needed during physical rehabilitation based on feedback from both the user's volitional movement and surface electromyogram (EMG) measurements. Pattern recognition techniques will be utilized with the EMG input to determine the user's intended complex hand movement. User input is incorporated during therapeutic training maneuvers to set the appropriate level of assistance to promote efficient motor learning in stroke survivors.

Public health relevance
PUBLIC HEALTH RELEVANCE: More than 795,000 people in the United States experience a stroke each year. Research has shown that stroke induced hand paralysis has a detrimental effect on health-related quality of life. Robotic stroke therapy devices have been shown to be a cost-effective means to assist with the labor intensive repetitive movement during physical rehabilitation and have demonstrated an advantage over conventional treatment.